Training Program on HIV and Substance Use in the Criminal Justice System

PROJECT SUMMARY
This T32 training program was established in 2014 to train the next generation of pre- and post-
doctoral scholars in the prevention, treatment, and care of HIV and substance use among individuals
involved with the criminal legal system (CLS). The training program is a partnership between the Columbia
University School of Social Work (SSW) and the Mailman School of Public Health (MSPH), with strong
support from longstanding partnerships with a number of research centers, schools, and departments at
Columbia University. We propose to renew the program by continuing its unique position as the only
NIDA-funded T32 program jointly run out of a school of social work and school of public health as well as
the successful administration and activities; the renewal will maintain that last cycle’s emphasis on
implementation and augment the program in: (1) community engagement, and (2) data science. The
training program provides: (1) interdisciplinary research instruction and training for pre-doctoral students
and post-doctoral fellows on the intersecting issues of substance use, HIV, implementation science,
community engagement, and data science with the CLS and CLS-involved populations; and (2) hands-on,
mentored experience conducting independent research in the program’s banner themes. This program is
designed to strengthen the pool of researchers by increasing the diversity of academic backgrounds—e.g.,
social work, public health, medicine, sociology, political science, anthropology—and those from
underrepresented populations—e.g., underrepresented minorities (URM), people with disabilities,
individuals from disadvantaged backgrounds. The participating faculty are scientific leaders in the fields of
CLS, HIV, substance use, implementation science, community engagement, and data science, with strong
track records of support from NIH; they are also well-qualified to provide training, as evidenced by their
strong records of mentorship of pre- and post-doctoral early career scholars. At capacity, the program
supports 4 pre-doctoral students and 4 post-doctoral trainees per year (a total of 6-8 pre-doctoral trainees
and 8-10 post-doctoral trainees in the renewal period). Thus, the program will add a substantial number of
highly qualified new scholars to the field focusing on HIV, substance use, implementation science,
community engagement, and data science among CLS-involved populations. Dr. Nabila El-Bassel and Dr.
Lisa Metsch will continue to serve successfully as PIs/Co-Directors for the proposed training program,
which provides an opportunity for two noted and distinguished scientists to collaborate and lead this
initiative. They contribute over 30 years each of experience in the program’s banner themes, shepherded
impressive growth in success in the program’s most recent cycle of funding, and will provide continuity in
leadership for the proposed renewal.

Public health relevance
PROJECT NARRATIVE This T32 trains pre- and post-doctoral scholars with diverse experiences from across the U.S., producing a well-trained generation of scientists who will be equipped to address some of the most pressing and/or entrenched problems affecting our country: HIV, substance use, and criminal legal system involvement. The forthcoming cycle will accelerate the implementation of high impact, science-based programs through a focus on implementation science, community engagement, and data science, altogether reducing health disparities and improving the health, well-being, and livelihoods of individuals, families, and communities highly impacted by the criminal legal system.